Houston Area Molecular Biophysics Program

[unreadable] DESCRIPTION (provided by applicant): The Houston Area Molecular Biophysics Program (HAMBP) is a Ph.D. research training program in molecular biophysics involving 52 faculty mentors in six educational/research institutions in the Houston-Galveston area: Baylor College of Medicine, Rice University, University of Houston, University of Texas-Houston Medical School, University of Texas M.D. Anderson Cancer Center, and University of Texas Medical Branch. Because of the large number of faculty, and the large and diverse applicant pool represented by this group of institutions, we propose to increase our number of funded trainees to 12. Students pursue a rigorous course of study in the classroom and in the laboratory. They receive a strong foundation in the fundamentals of Molecular Biophysics, exposure to a broad range of topics, and pursue cutting-edge thesis research in world-class biophysics laboratories. Research areas include x-ray crystallography, macromolecular electron microscopy, fluorescence, magnetic resonance and other types of macromolecular spectroscopy, thermodynamics, kinetics, molecular dynamics, theoretical biophysics, protein folding, nucleic acid structure, molecular recognition, and others. Biological structures studied range in size from peptides and lipid mediators to viruses, transcription complexes, and muscle filaments. Supported trainees have included 4 underrepresented minorities, and have had average GRE scores of 83%tile (Q), 81%tile (A), 79%tile(V), and 71%tile (Adv.), with average undergraduate GPAs of 3.55/4.0. The average number of publications per trainee is 6.4 for past trainees, and 4.6 for all trainees, including many high-profile papers and journal covers. Alumni have secured excellent positions upon completion of training, and continue to perform research at a high level. The Program is administered by a Steering Committee of representatives from all partner institutions, which closely monitors the progress of trainees, and make decisions about admission of applicant students and mentors. HAMBP is one of several highly successful cooperative training and research ventures of the partner institutions, which together represent a larger pool of research resources and trainees than any single institution in the U.S. [unreadable] [unreadable]